Midwest Pediatric Device Consortium (MPDC)

Summary
The Midwest Pediatric Device Consortium (MPDC) has been created to address unmet needs in pediatric
medical device development. Founded at Nationwide Children’s Hospital (NCH) and The Ohio State University
(OSU) in Columbus, Ohio, MPDC will use funds from the FDA Pediatric Device Consortia (PDC) program in
support of its mission to provide funding and business, legal, organizational, clinical, engineering and scientific
resources to inventors of pediatric medical devices having significant commercialization potential and that
address pediatric health needs. NCH and OSU both maintain national prominence in clinical care and research.
Teaming with other pediatric healthcare organizations including Cincinnati Children’s and Cleveland Clinic
Children’s establishes a vibrant and comprehensive medical device development ecosystem for our region and
provides diversity in leadership, participation, community engagement and economic opportunity. MPDC is also
powered by Ohio’s Trade Organizations, including Jobs Ohio and Ohio Life Sciences, to leverage their network
of connections and state legislative influence. Lastly, MPDC engages with several venture funds including Rev1
Ventures, CincyTech, and Project MedTech, having considerable resources and experience bringing startup
companies forward. Participating organizations of the MPDC have already assisted a large number of devices
along the development pathway, demonstrating the business experience and stewardship of ideas necessary
for programmatic success. The full range of support is offered to innovators by the MPDC network, comprised
of preeminent experts in their field who will provide advice, education, guidance and funding to help lead device
development through the pipeline to commercial success. Our Executive Committee and Advisory Committee
are made up of clinicians, scientists, business and manufacturing experts who are thought-leaders in their fields.
They will evaluate the clinical and business merits of every device project submitted for evaluation and funding.
MPDC’s organizational structure includes a broad spectrum of leaders who are able to assess the value
proposition, reimbursement, regulatory, marketing and business strategy of each proposed device as a cost-free
service. MPDC will implement its comprehensive plan to foster collaboration, diversity, equity, and inclusion as
a leader in creating a national network benefiting all pediatric patients MPDC will also provide unique real world
evidence through projects specifically crafted to capture data streams as well as develop mechanisms to collect
new data to support pediatric device label expansion. MPDC will be a beacon of pediatric medical device
innovation through its bridging of academic researchers, inventors, entrepreneurs and industry partners in an
integrative program to transform pediatric healthcare through advancement of new and needed technologies.

Public health relevance
Narrative / Public Health Relevance Statement The Midwest Pediatric Device Consortium (MPDC) will provide critical funding as well as business, legal, organizational, clinical, engineering and scientific resources to innovators for creation of pediatric medical devices having significant commercial potential and that improve healthcare for children.